MEASUREMENT OF MEMBRANE IONIC CHANNELS IN CHROMAFFIN CELLS

Instrumentation and analysis have been developed for the measurement of ionic currents in the bovine chromaffin cell using whole cell and single channel recording. Instrumentation includes a current-to-voltage converter, an AT microcomputer system, a PACE computer system, voltage stimulator, filter, and threshold detector. Measurements of event durations and event amplitudes for different membrane potentials and appropriate inhibitory drugs (example: muscarine) were performed on the collected data. The events were collated and then fit to appropriate functions that characterized the population.